2022 Aspen/Snowmass Perinatal Biology Conference

This application seeks funding for travel costs to allow the attendance of 12 trainees or new investigators from
the USA and speakers' fees for 6 invited early career speakers at the 2022 Aspen/Snowmass Perinatal Biology
Conference. The longstanding tradition of perinatal research in the US underpins our knowledge of the
physiologic basis of fetal development. Cellular and molecular techniques incorporated into investigation in the
last 20 years have allowed in depth understanding of the developmental basis of fetal physiology and the
pathophysiology of preeclampsia, IUGR, diabetes and premature delivery, conditions associated with perinatal
morbidity and mortality. There has been a burgeoning recognition that life in utero is associated with the
development of disease in adult life, i.e. the developmental origins of health and adult disease or fetal
programming. This has brought renewed interest in perinatal physiology. The perinatal research community is
multidisciplinary; bringing together clinicians and basic scientists interested in maternal, fetal, and placental
physiology and a substantial cadre of agricultural animal scientists who perform comparative studies of great
relevance to human physiology and development. It also has a strong tradition of training young basic and
clinician scientists. A vital part of their training experience is the opportunity to present work in venues where
they can interact with senior scientists and receive the benefit of mentorship from role models. This meeting
will feature presentations from maternal, fetal, placental and agricultural animal researchers around an
integrated theme of "Developmental Programming- Putting the Pieces Together'. The meeting will be 3 and
1/2 days with multiple oral plenary sessions including new investigators. Plenary sessions will be accompanied
by several interactive workshop sessions addressing key questions and challenges facing young investigators
in perinatal biology. New to this 2022 conference are a number of activities, including a mentoring workshop
and a "Meet the Expert" breakfast for trainees and junior faculty that are under-represented in perinatal biology.
Two poster discussion sessions are scheduled, and posters will be displayed for the entire meeting to allow
time for in-depth discussion of work. Prizes will be awarded for the best poster presentations by trainees or
new investigators. Trainees and new investigators will be selected based on review of submitted first author
abstracts by the Scientific Advisory Committee for award of travel funds. There has always been a high
proportion (over 50% at our last meeting) of women attendees at previous meetings and women speakers and
session chairs at this meeting are well represented. Our URM representation is around 15%, and we will
continue efforts to improve this number, especially with the designation of a minimum of 33% of the requested
budget used for travel by URM young investigators. Our selected venue is compliant with the Americans with
Disabilities Act and provides childcare and numerous family activities to facilitate attendance by all individuals.

Public health relevance
The purpose of this conference grant application is to provide travel funds for 12 trainee/young investigators and 6 early career speakers to help support their attendance at the 2022 Aspen/Snowmass Perinatal Biology Conference. This area of investigation has major public health consequences with the growing recognition that life in utero is a major determinant of disease in adult life. The conference will bring together in an integrated manner maternal, fetal and placental physiologists together with agricultural scientists who study various mechanisms for developmental programming which often result in similar developmental outcomes in the offspring.